Phosphoinositide signaling in glaucoma: rescue strategies for Lowe syndrome

ABSTRACT
Glaucoma is a leading cause of irreversible blindness. Lowering intraocular pressure (IOP) is the
only modifiable target for intervention, but the mechanisms causing elevated IOP remain poorly
understood. This proposal builds on our studies of oculocerebrorenal syndrome of Lowe, a rare
X-linked disease that presents with congenital glaucoma, the major cause of blindness in these
children. OCRL is an inositol phosphatase mutated in Lowe syndrome. This application seeks to
restore the phosphoinositide imbalance that underlies Lowe syndrome by targeting inositol-signaling
pathways. We have found evidence that restoring phosphoinositide levels in trabecular meshwork
cells can rescue the disease in a Lowe mouse model. We have identified patients with Lowe syndrome
who are born with congenital glaucoma and have characterized their mutations. We also discovered
mTOR signaling defects in these patients. Thus, we hypothesize that modulation of phosphoinositide
signaling in the trabecular meshwork will restore aqueous outflow. Our aims are to (1) restore
aqueous outflow by viral delivery of OCRL, (2) balance excess PI(4,5)P2 by inhibiting upstream
kinase, (3) modulate mTOR signaling in both the mouse model and a human iPSC model of Lowe
syndrome. Our work should help determine the role of OCRL in aqueous outflow regulation. Since
phosphoinositide signaling is a novel area of IOP control, the experiments should facilitate
discovery of new glaucoma therapies that can reduce the burden of blindness.

Public health relevance
Glaucoma is a leading cause of blindness worldwide and lowering eye pressure is the only proven treatment. We have discovered a novel pathway that is disrupted in Lowe syndrome, a rare disease that causes glaucoma in children, and which leads to abnormally high intracellular levels of phospholipids. The proposed studies will restore the lipid imbalance that underlies Lowe syndrome and we anticipate that this study will lead to novel therapeutics not only for this disease, but also for other more common forms of glaucoma.